Uncovering the physiological role of functional hyperemia

Neuronal activation leads to increases in blood flow to the region. Since its discovery in the 19th century, this
phenomenon – termed functional hyperemia – has been thought to provide increased energy nutrients to
sustain the increased neural activity. Impaired functional hyperemia is seen in many neurodegenerative
diseases including Alzheimer's disease (AD). However, these diseases also manifest reduced baseline flow
levels, making it difficult to determine the importance of functional hyperemia per se in sustaining healthy
neuronal function. Functional hyperemia also forms the basis of many imaging techniques (such as fMRI), that
take advantage of the spatially localized blood flow increase to infer the location of neural activity from
vascular/metabolic measures. Despite the widespread importance of understanding functional hyperemia for
neuroscience, the impacts of eliminating only the activity-induced increase in blood flow – without altering
baseline flow levels or the activity of neurons and other cortical cells – are still unknown. This proposal will
determine how neuronal activity and neuro-metabolism are affected in health and in Alzheimer's
disease when functional hyperemia is blocked. We recently developed a model system to block functional
hyperemia using optogenetics. To our surprise, we found that sensory-evoked neuronal responses were not
diminished when functional hyperemia was blocked. In Aim 1 we will build on this preliminary data by studying
what aspects of neural responses to sensory stimuli are altered by the loss of functional hyperemia. Two-
photon calcium imaging will be used in mouse primary visual cortex to quantify how the response amplitude
and selectivity to stimulus attributes (orientation selectivity) of excitatory and inhibitory neurons are affected.
Using electrophysiology, we will determine if temporally precise aspects of neuronal activity, such as spike
timing and network synchrony (i.e. gamma oscillations) are altered. Our working hypothesis is that blocking
functional hyperemia impairs the cellular machinery involved in generating action potentials (such as restoring
ion gradients). However, these consequences may not initially appear as reduced response levels, but rather
as alterations in spike timing, excitatory/inhibitory balance, network synchrony, and information encoding. We
will also determine if healthy young brains have the capacity to buffer the loss of functional hyperemia in ways
that a diseased brain cannot by blocking functional hyperemia in a mouse model of AD. This will also shed light
on the relative importance of reduced functional hyperemia versus baseline flow levels in AD pathology.
In Aim 2 we will study how neuronal metabolism is affected by blocking functional hyperemia. We will record
the concentrations of oxygen, glucose, lactate and ATP in the tissue to determine how blocking functional
hyperemia affects the levels of these metabolites and if it leads to altered metabolic processing in neurons. We
will also quantify how the vasculature reacts to temporary reductions in blood flow. This proposal will define the
role functional hyperemia plays in maintaining the moment-to-moment metabolic needs of neurons.

Public health relevance
PROJECT NARRATIVE Many neuro-degenerative/cognitive disorders manifest vascular impairments, including reduced functional hyperemia. However, isolating the impact of reduced functional hyperemia from other vascular changes is technically challenging. This proposal will harness a novel technique to block functional hyperemia independently from other vascular changes to determine the impact on neural function in health and in Alzheimer's disease.